Regulation of protein synthesis by metabolic signals and the circadian clock

Project Summary
Protein synthesis is a core function of all cells and is the target of multiple signaling pathways that coordinate
the translation of mRNAs into proteins in response to exogenous and internal signals. Work from this and other
laboratories has highlighted that cyclical signals from the light environment, temperature, metabolic
biomarkers, and the circadian clock are integrated to coordinate mRNA ribosome loading on a genome-wide
scale. Central in this network is the signaling axis known as the TOR-S6 kinase pathway. It regulates the
phosphorylation of several components of the cytosolic translation apparatus including one prominent target on
the ribosome, the eS6 protein located at the foot of the small ribosomal subunit. The model system underlying
the current project, Arabidopsis thaliana, is not only representative of higher eukaryotes because of the
conservation of its TOR-S6K-eS6 signaling channel, but is also an ideal system to study the integration of
various cyclical signals in a chronobiological context. The first aim of the project builds on innovative and
established molecular, biochemical, and cellular assays to tackle a long-standing question, the biochemical
and cellular role of eS6-phosphorylation. Plants in which phosphorylation of eS6 is abolished or otherwise
disrupted display at most minor defects in their growth, development, and transcriptome. Therefore, detailed
assays of translational fidelity, ribosome biogenesis, translation, and autophagy will be refined and applied to
identify the biochemical and cellular scope of eS6 phosphorylation. The second aim is a collaboration with a
group of versatile computational biologists under co-investigator Tian Hong. As the cell processes multiple
independent circadian signals, it can be predicted theoretically that the precise mode of their integration will
lead to new circuit properties including complex waveforms or even ultradian periods. The project will use
bioinformatic data mining, mathematical modeling, and wet-lab experimentation to distinguish between
competing hypotheses to explain how multiple cyclical signals are integrated with each other.

Public health relevance
Narrative Protein synthesis is regulated by multiple signaling pathways, which converge, among other targets, on the phosphorylation of the ribosomal protein eS6. This project utilizes innovative assays to ascertain the biochemical and cellular role of eS6 phosphorylation and explores the mathematical underpinnings for the integration of cyclical energy signals with cyclical signals coming from the circadian clock. This fundamental knowledge may inform technical progress on the chronopharmacology of drugs that impact the protein synthesis machinery.